Genome Sequencing in support of the Gabriella Miller Kids First Pediatric Research Program Supplement

ABSTRACT
We propose to continue to provide data generation and processing activities that
will enrich a genomic data resource to propel pediatric disease research and in particular
the Pediatric MATCH trial cohort covering matched diagnostic and refractory tumor
samples. Key elements to a successful program will be the provision of high quality
genome sequence data on well-phenotyped patients, the collection and accessibility of
data to the research community in an intuitive manner, and the integration of genetic data
with phenotypic information in the context of this program and comparison to other large
data resources.
We propose to continue as a Kids First Sequencing Center at the Broad Institute as
we have done for the past seven years for the program and as we have also done in
support of other large flagship NIH genome projects. With this supplement, we will bring
to bear our expertise in our somatic product offerings. Our center brings the domain
expertise in high throughput data generation, processing and analysis, and disease gene
discovery required to meet the objectives of the Kids First Program and NCI's Childhood
Cancer Data Initiative (CCDI).
We will apply deep, high-quality whole genome sequencing data on selected
samples. We will be flexible to work closely and accommodate the needs and interests of
selected X01 Investigators. We are flexible to a mix of cohort types, whether they are
tumor/normal pairs or quads. We will also work with X01 Investigators to generate whole
exome data at 100X coverage on selected samples. Additionally for samples that need
further investigation at the transcriptome level, we will generate RNASeq data using a
pipeline developed for challenging samples. We will participate in the evaluation of these
data types and their overall impact on discovery and scientific output of the program.

Public health relevance
NARRATIVE The overall goal of this supplemental project is to generate high quality sequence data to help complete genomic characterization of the Pediatric MATCH trial cohort. The project focuses on ensuring data accessibility to the research community and integrating genetic data with phenotypic information, aligning with the objectives of the Childhood Cancer Data Initiative to create a scientifically compelling dataset that combines clinical trial data and comprehensive genomic characterization efficiently.